Clinical Ecosystem Surfaces for Improved Disinfection Outcomes and the Prevention of HAI Transmission

Project Summary Abstract
Health care-associated infections (HAIs) are all too common in today’s hospital
environment. More than 1.7 million cases of transmission occur annually and often the
implicated infectious organisms are transferred from inanimate objects capable of
sustaining their viability. The disinfection methods that are used routinely in hospitals
today are imperfect and the only available and accepted methods for minimizing patient-
to-patient transmission include: 1. improved cleaning and disinfection of room surfaces,
2. implementation of 'no touch' methods for terminal room disinfection, e.g., ultraviolet
light or hydrogen peroxide vapor, and 3. use of 'self-disinfecting' surfaces to reduce the
bioburden on hospital surfaces.
Current 'self-disinfecting' clinical surfaces with the antibacterial label are limited to
painted surfaces incorporating quaternary ammonium compounds (QACs, Sherwin
Williams Paint Shield®) and more recently a PPG paint (Copper Armor®) comprising
ceramic encapsulated copper oxide Guardiant®, Corning).
In the proposed effort, a novel organometallic copper additive is scaled and its
manufacturing validated and liquid and powder paint formulations created, validated, and
tested for effectiveness against bacteria, viruses, and fungi. These data will be used to
support an EPA filing for products incorporating the novel additive. The major elements
of the specific aims of the proposed research involves: 1. The scaling and manufacturing
(synthesis) validation and characterization of ion exchange biocides, 2. Subsequent
formulation into two distinct coating forms, and 3. The evaluation of the time-dependent
biological performance of the modified composites under ISO 17025 and GLPs so as to
support an application to the EPA.

Public health relevance
Project Narrative In the United States, approximately 1.7 million health care-associated infections (HAIs) occur in hospitals annually. Many of the implicated organisms are transmitted to the patient by a health care worker via an intermediary in the hospital environment, i.e., a fomite. Fomites are nonliving objects, substances, and surfaces capable of carrying infectious organisms. With costs to treat these infections requiring more than billions of dollars annually, improved methods of preventing HAIs are needed. The proposed project addresses this complex problem with the development and testing of two first-in-class solutions that will address bacterial, fungal and viral threats within the clinical and other environments.